Individual and Community Level Determinants of Vitamin D Deficiency in Pediatric Chronic Kidney Disease

Children with chronic kidney disease (CKD) are plagued by debilitating cardiovascular and mineral bone disease (CKD-MBD) with cardiovascular mortality rates that are 1000 times greater and fracture rates that are 2 to 3-fold higher than in healthy children. Our previously published work demonstrated population-level differences in CKD-MBD including differences in cardiovascular mortality and differences in the bone biomarkers 25-hydroxyvitamin D and parathyroid hormone (PTH). There is limited understanding of nonclinical correlates like the impact of socioeconomic status on long- and short-term CKD-MBD outcomes. Given the reliance of this life-limiting comorbidity on dietary intake and health behaviors, there is a critical need to define intervenable social-environmental characteristics that impact CKD-MBD outcomes. As such, the objective of this application is to integrate clinical data and the social determinants of health to map the social-environmental exposome and define its relationship to CKD, particularly vitamin D status. The central hypothesis of this research is that adverse social-environmental characteristics increase the risk of CKD comorbidities like vitamin D deficiency. Aim 1 will develop a facile, secure SDOHKIDney dataset that integrates data from electronic health records and geocoded census-level data on the social determinants of health. Aim 2 will use SDOHKIDney to define social-environmental risk factors for vitamin D deficiency. This work will expand upon my current K23 which seeks to understand the genetic contributions to population-level differences in CKD-MBD and set the foundation for investigations of gene by environment interactions and the impact of early CKD interventions on vitamin D on CKD outcomes like progression and hyperparathyroidism.

Public health relevance
PROJECT NARRATIVE Children with chronic kidney disease (CKD) are plagued by debilitating mineral bone disease (CKD-MBD) with fracture rates that are 2 to 3-fold higher than in healthy children. This study will examine the impact of individual- level social needs and community-level social determinants of health on vitamin D deficiency in pediatric chronic kidney disease. The proposed study will address an important cofounder (i.e., socioeconomic status) to future R01 research aimed at defining and addressing patterns and mechanisms of racial-ethnic differences in pediatric CKD-MBD.